Neurovascular dysfunction in delirium superimposed on dementia

ABSTRACT As many as 20-30% of all COVID-19 patients develop delirium during hospitalization, an estimate that increases to 60-70% in those that develop severe illness. Delirium is a well-established risk factor for dementia, thus the impact of the ongoing pandemic on neurodegeneration will be long-lasting. In particular, we hypothesize that COVID-19 infection will accelerate the progression and emergence of Alzheimer’s Disease Related Dementias (ADRD) in the elderly by increasing both peripheral and central inflammation as well as decreasing the ability of the lungs to supply the brain with sufficient oxygen to maintain normal cognitive function. This supplement to RO1AG057525 “Neurovascular dysfunction in delirium superimposed on dementia” seeks to model the systemic impact of inflammation, akin to the pathology reported in patients with COVID-19 infection, on the central nervous system (CNS) by focusing on the neurovascular unit (NVU) and delirium-like behavior as key endpoints from our parent grant. Furthermore, we have recently reported on the protective effects of our drug in development, URMC-099 on the NVU after orthopedic surgery in mice with ongoing neurodegeneration. We are well-positioned to rapidly evaluate the effects of this therapy after lung injury using methodological approaches established for our parent grant. Our overall objective for this supplement is to determine the impact of the inflammatory milieu on the NVU and cognitive function after lipopolysaccharide (LPS) inhalation as a simplified model of COVID-19- related delirium. The central hypothesis is that inhaled LPS induces platelet aggregation, neutrophil adhesion, and neurovascular hypoxia ? key pathologic hallmarks found in patients with COVID-19. We contend that these sequelae are preventable by treatment with the brain penetrant mixed-lineage kinase (MLK) inhibitor URMC- 099. Our hypothesis is based on preliminary data acquired in the applicants’ laboratories and will be tested by pursuing 2 specific aims: 1) To implement an inhaled LPS-based lung injury model to translate the clinical features of systemic COVID-19 infection by quantifying indices of neutrophils, neutrophil extracellular traps (NETs), platelets and cytokine release syndrome as the basis for CNS dysfunction; 2) To define inflammatory events at the NVU and related cognitive impairment in mice treated with inhaled LPS and reposition URMC-099 to prevent these sequelae. Feasibility for these models and techniques has been established in the applicants’ hands. In this innovative approach, real-time in-vivo brain imaging and postmortem analyses will be combined with novel behavioral assays to define delirium-like changes in mice. The rationale for the proposed research is that successful completion will advance our understanding of how COVID-19 affects CNS function and provide new molecular mechanisms of relevance to aging, delirium, neurodegeneration, and the Alzheimer's Disease and Related Dementias at-large. Such knowledge is highly significant because COVID-19 infection during this pandemic will impact millions of older adults and at-risk patients in the United States with ongoing neurodegeneration and dementia.

Public health relevance
PROJECT NARRATIVE In the U.S., COVID-19’s greatest impact on morbidity and mortality has been the elderly in nursing homes, who are highly vulnerable to delirium, which is a known risk factor for dementia in older adults. Here, we will develop a model of COVID-19 lung injury that activates the immune system to damage the brain, affecting areas that serve attention, memory, and thinking and reverse these changes with an experimental drug in development. Findings from this research supplement will address this serious public health concern by providing fundamental knowledge to advance the therapeutic development of a drug to reduce the healthcare burden of COVID-19 associated delirium and Alzheimer's disease and related dementias (ADRDs).